Administration - Core C

This Specialized Program of Research Excellence (SPORE) grant is intended to support multi-project,
interdisciplinary and multi-institutional translational research in glioma. The governance structure of this Dana-
Farber/Harvard Cancer Center (DF/HCC) SPORE grant provides the foundation for the implementation,
execution and ultimate success of all projects and cores. The Administration Core serves as the “hub” for this
governance structure and aims to achieve a number of specific objectives as defined below. We will execute a
plan that provides experienced, centralized program leadership and administration. The Glioma SPORE
Director and Co-Director are senior administrators, institutional leaders, and researchers who have worked
together on the current funding period for this SPORE and on prior DF/HCC initiatives and, consequently,
provide consistent, strong, complementary leadership for the grant. The trans-institutional administrative team
consists of senior personnel at DF/HCC institutions who have worked together effectively in the current funding
period of this grant. We will expand our management to an external, funded component (Project Four) of the
SPORE at Stanford University Medical Center and to both adult and pediatric patient populations. We
maintain two senior clinical and imaging scientists in the Administration Core to supervise Glioma SPOREspecific
clinical trials and Glioma SPORE-specific imaging studies, respectively, and to enable this Glioma
SPORE to capitalize on existing DF/HCC P30 Cores to support these types of studies. We have established
and utilized an effective internal and external committee structure to provide multidisciplinary expertise, advice
and oversight of the program. Each of the committees consists of collaborative, complementary members who
have worked together in the current funding period of this SPORE or on prior projects. A series of regular
Glioma SPORE meetings involving both administrative and scientific SPORE personnel will continue to
facilitate close collaboration, troubleshooting, and monitoring of the SPORE program. We will continue and
expand an effective internal and external communications program, which includes a Glioma SPORE-specific
component. An established and extensive DF/HCC communications infrastructure is utilized to promote open,
regular, trans-institutional communication regarding SPORE opportunities and activities. We will reinforce an
active SPORE program to enhance participation by underrepresented minorities and women.

Public health relevance
Primary brain tumors, including high-grade gliomas, are the third leading cause of cancer-related death among all persons 15-39 years of age (http://www.CBTRUS.org). In the fullness of time, the work that we propose with targeted therapies could change the standard of care and improve adult and pediatric patients with gliomas. The Administration Core serves as the "hub" for the governance of this SPORE research program.